Centralized Resource to Accurately Quantify Latent and Expressed HIVReservoirs

PROJECT SUMMARY/ABSTRACT
Human immunodeficiency virus type-1 (HIV-1) is a retrovirus that infects CD4+ T cells of the immune
system. If left untreated, HIV-1 infected individuals will progress to AIDS and may ultimately die as a result.
Combination antiretroviral therapy is extremely effective at stopping the replication of HIV-1 in infected
individuals. Despite the success of this therapy at suppressing HIV-1 replication to clinically undetectable
levels, antiretroviral therapy is not curative. This is due to the persistence of HIV-1 in a silent, or latent, state
within a subset of CD4+ T cells known as resting memory CD4+ T cells. In this latent state, these infected cells
are not targeted by antiretroviral drugs and cannot be eliminated by the immune system. In HIV-1 infected
individuals, latently infected CD4+ T cells are found at extremely low frequencies (~1 per million resting
memory CD4+ T cells), with the majority found within immune tissues at any given time. This population of
latently infected cells is very stable, demanding that HIV-1 infected individuals remain on antiretroviral therapy
indefinitely to avoid rebound of viremia. As such, this population of latently infected CD4+ T cells is the main
barrier to curing HIV-1 infection.
Developing strategies to eliminate latently infected cells is a major focus of the NIH, NIAID, and the
HIV-1 research field. To demonstrate the efficacy of therapeutics targeting the latent reservoir, we must be
able to measure the frequency of latently infected cells using rapid and accurate assays that can be scaled for
widespread clinical use in both peripheral blood and immune tissues. Accelevir Diagnostics, LLC therefore
developed, scaled, and is currently operating an NIAID resource to perform an array of innovative molecular
and genomic assays to accurately measure the size of the latent reservoir, the amount of residual viremia
present in the peripheral blood, and the transcriptional activity of persistent proviruses to support research,
preclinical, and clinical studies. This resource has already supported over 100 projects across the HIV-1 cure
research field, producing over 10,000 test results. Broadly, this renewal proposal will fund the continued
operation of this important resource and expand the menu of viral persistence assays offered to support global
research efforts.

Public health relevance
PROJECT NARRATIVE For people living with HIV-1, including those on effective antiretroviral therapy, a reservoir of latent virus persists in memory CD4+ T cells necessitating life-long treatment to prevent disease progression. Targeting this HIV-1 latent reservoir with new therapeutics is being pursued as a strategy to definitely cure the infection. In this grant renewal proposal, we aim to continue operating our centralized NIAID testing resource, providing an expanding menu of optimized molecular, genomic, and cell-based assays for the HIV-1 latent reservoir to support research studies and clinical trials across the HIV-1 cure research community.